Integrated exposome profiling to identify environmental risk factors of metabolic disease in mid- and late-life

PROJECT SUMMARY/ABSTRACT
Exposure to environmental chemicals may play an important role in the pathogenesis of type-2 diabetes (T2D)
and metabolic syndrome (MetS) as these exposures are widespread in the population, and the prevalence of
these metabolic disorders has dramatically increased over the past several decades. In the US, >42,000 types
of chemicals are actively produced, but only a handful of chemicals are tested for their toxicity. Epidemiologic
studies have also been restricted to a few targeted metabolism-disrupting chemicals, while relatively little is
known about the potential metabolic toxicity of the majority of these chemicals. Analyses spanning wide
classes of chemicals are critically needed to identify novel areas of risk, as well as specific associations with
metabolic phenotypes. In addition, the underlying biological mechanisms linking environmental chemicals and
T2D and MetS are still not well understood. Although risk assessment is critical for early detection and
prevention of T2D and MetS, current risk prediction models generally use only a few known risk factors such
as demographics, clinical measures including fasting blood glucose and body mass index, and family history
and susceptible genotypes. Integrated exposomic signatures may improve risk stratification/discrimination to
identify vulnerable populations and provide a more effective intervention approach at the individual- and
population-level (i.e., precision health). To address these scientific gaps, we propose to conduct an exposome-
metabolome wide association study in relation to incident T2D and Mets in the Study of Women’s Health
Across the Nation (SWAN), a multi-racial/ethnic longitudinal cohort of women from midlife to late-life. Using
untargeted, high-resolution mass spectrometry that provides the high-quality measures needed for sequencing
the human blood exposome, we aim to establish a new paradigm for environmental health research
addressing metabolic disease risk. This can be achieved by taking advantage of the rich longitudinal features
of the SWAN. Specifically, we aim to 1) conduct an integrated exposome- and metabolome-wide association
study of incident T2D and MetS using pre-diagnosis blood samples collected at baseline to characterize known
and novel environmental exposures detected using untargeted high-resolution mass spectrometry linked to
future T2D and MetS risk and identify endogenous metabolite and disease-associated alterations underlying
T2D and MetS; 2) evaluate temporal evolution of exposome and metabolome profiles in T2D and MetS cases
and metabolically healthy controls; 3) identify pre-diagnostic metabolomic signatures that link targeted
exposures of metabolism disrupting chemicals and novel exposome biomarkers to incident T2D and MetS; and
4) develop and validate exposome-based risk prediction models for T2D and MetS. Successful completion of
these aims will identify critical pre-diagnostic exposome biomarkers that may improve risk prediction for T2D
and MetS.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because given the widespread exposure to metabolism disrupting chemicals and the burden of T2D and MetS in the United States and globally, the public health impact would be substantial if these modifiable exposures are reduced. The findings of this project will highlight the clinical and public health utility of exposome for risk assessment, prevention, and precision health which will effectively reduce metabolic disease risk.